Broadly neutralizing antibody combinations with single virions in HIV+ plasma

Certain broadly HIV-neutralizing antibodies (bnAbs) are being actively investigated as agents for HIV/AIDS
treatment, functional cure and/or prevention. These bnAbs are classified according to cognate epitopes clusters
on the HIV envelope (Env). Rigorous preclinical studies evince several potential advantages of bnAbs over
currently used antiretroviral drugs (ARVs) in various settings. Currently, optimization of breadth, potency, and
virus escape resistance are primary goals for clinical development. A major issue is that all single bnAbs exhibit
limited coverage of epitope variability/mutability among HIV strains, allowing virus escape. A lead mitigation
strategy proposes triple combinations of bnAb classes for clinical intervention under the premise that polyspecific
reactivity will boost potency and breadth. However, the identification of promising combinations is challenging.
Screening through all possible triple combinations; bnAb class members; and engineered class members via
clinical trials or animal models is an expensive and lengthy process. Therefore, the advancement of bnAb
combinations requires a rational, preclinical selection process based on in vitro analytical systems that inform
prospects for efficacy. Standardized neutralization assays will continue to play an important role; however, the
data can overestimate in vivo potency and escape resistance, fail to capture important determinants of
combination bnAb action, and appear incongruous with clinical outcomes in bnAb prevention or therapy trials.
Past trials of mono or dual bnAb therapy did not achieve sustained virus suppression of viremia; in some cases,
viral rebound occurred via resistance to only one bnAb. This experience reinforces the need for new analytical
techniques that capture additional determinants of potency and escape resistance more thoroughly. Such efforts
should focus on bnAb interactions with wild type virus swarms in plasma, as these are targets for infused bnAbs
and mediate transmission and disease. The development of combination ARV therapies points to instantaneous
inhibition and concurrent bnAb class action as highly relevant measures of potency, breadth, and escape
resistance. The goal of this project is to introduce new capacities to take these measures for various bnAb
combination and test settings, including wild type virus populations in plasma. In ongoing studies, we developed
novel quantitative single molecule and fluorescence correlation spectroscopy (FCS) detection methods that can
directly measure qualitative and quantitative aspects of triple bnAb class binding to virus populations in plasma.
We hypothesize that our goals will be met by innovative applications of these techniques toward analyses of
bnAb combinations and plasma viruses. Two Specific Aims are: 1) Establish and interpret the interactions of
bnAb combinations with single virions or Env trimers measured by FCS techniques. 2) Characterize interactions
of bnAbs and bnAb combinations with single virions in HIV+ plasma. This project will yield innovative new tools
for evaluating the potency, breadth, and escape resistance of bnAb combination in highly relevant settings of
wild type viruses in plasma that are not efficiently explored by current methods.

Public health relevance
Establishing how combinations of broadly HIV-neutralizing antibodies (bnAbs) with different epitope specificities can be most effectively used to cover HIV variants would have significant impact on the development of approaches to prevent or treat HIV infection. This project will uniquely focus on, and determine, the reactivity of single virions with multiple bnAb classes in situ. The data will fill key information gaps in the process of deciding how to best use bnAb combinations for HIV prevention and therapy.